Biomarkers of Kaposi sarcoma recrudescence in Zambia

PROJECT SUMMARY/ABSTRACT
The “Role of Human papiloma vírus and HIV in Penile Cancer Progression” study will investigate the
association between presence of human papilloma virus (HPV) in penile cancer tumors and HIV co-infection
with stage at presentation of penile cancer. Penile cancer is an aggressive malignancy that develops in the
skin and tissues of the penis. The etiology of penile cancer is not completely understood. However, several
factors including infections (HIV, Human Papillomavirus (HPV), other sexually transmitted infections), poor
hygiene, advanced age, smoking, trauma, and inflammatory conditions have been associated with penile
cancer development. In our setting, penile cancer patients present at a much younger age, and mostly among
HIV infected individuals, than in developed countries. Even though HPV is associated with penile cancer, the
presence of HPV in penile cancer ranges from 20-80%. Despite HPV being thought to play a role in penile
cancer development, some studies have found that the presence of high-risk HPV in penile tumors is
associated with a better outcome. The main objective of this study is to investigate the role of HPV and HIV in
penile cancer progression, and to recruit and train an early investigator in the area of HIV-associated
malignancies. The site for this study has a high incidence of penile cancer patients. The long-term goal of this
study is to determine how the immune response can be utilized in order to limit the progression of penile
cancer. Three specific aims will be accomplished: 1) Recruit, support, and mentor Dr. Victor Mapulanga to
Study Penile Cancer; 2) Recruit and characterize penile cancer patients clinically, histologically, and by HPV
status; and 3) Compare the presence of tumor infiltrating lymphocytes, resident memory T cells, and markers
of immune exhaustion in penile tumors by HPV and HIV status. In summary, this study will investigate the role
of HPV and HIV in penile cancer stage at presentation.

Public health relevance
NARRATIVE Cancer of the penis is an aggressive malignancy that has a high incidence in some developing countries including Zambia, and especially among people living with HIV. Presence of human papilloma virus (HPV) in the tumor has been associated with lower stage disease. This study will focus on how HPV and infection with HIV affects the tumor environment and stage at presentation of penile cancer.